Endothelin-1 signaling in microvascular responses to insulin and the role of physical activity and sedentary behavior in women with a history of gestational diabetes mellitus

PROJECT SUMMARY/ABSTRACT
The purpose of this Ruth L. Kirschstein National Research Service Award is to provide support for Grace
Maurer, a Ph.D. student in Dr. Anna Stanhewicz’s laboratory at the University of Iowa, to conduct research that
will prepare her to become an independent investigator in the field of maternal cardiovascular health. As part of
her proposed training plan, she will learn a variety of new technical, conceptual, intellectual, and professional
skills and refine research skills currently under development. Women who experience gestational diabetes
mellitus (GDM) are 7 times more likely to develop type II diabetes and 2 times more likely to develop
cardiovascular diseases than women who had an uncomplicated pregnancy. Microvascular dysfunction,
mediated in part by decreases in the vasodilatory molecule nitric oxide, is likely a key mechanism contributing to
reductions in microvascular insulin-mediated dilation and subsequent overt disease development in this
population. Understanding the mechanistic underpinnings of this microvascular dysfunction prior to overt disease
in this high-risk cohort of women is required to determine the pathophysiology of disease and identify
mechanism-specific interventional approaches and is therefore an important biomedical research priority.
Additionally, physical activity and sedentary behavior influence vascular function and disease risk in clinical
populations (e.g. obesity, type II diabetes) but have not been mechanistically explored in healthy women with a
history of GDM. Supported by strong scientific premise and compelling preliminary results, Grace will use
an innovative human approach – leveraging the cutaneous circulation as an in vivo model of global microvascular
function – coupled with device-based assessments of physical activity and sedentary behavior to determine the
extent to which insulin-mediated endothelin-1 responses attenuate microvascular vasodilation in women with a
history of GDM (Aim 1), and delineate the degree to which device-measured free-living physical activity and
sedentary behavior predict microvascular endothelial responses to insulin in healthy control and GDM women
(Aim 2). The proposed research will be the first to assess the mechanistic role of endothelin-1 on microvascular
insulin-dependent responses and to examine physical activity and sedentary behavior and their impact on
microvascular responses in women who had GDM after pregnancy but before overt disease development. This
F31 fellowship project addresses important NHLBI research objectives to: 1) investigate newly discovered
pathobiological mechanisms important to the onset and progression of heart, lung, blood, and sleep diseases,
and 2) develop and optimize novel diagnostic and therapeutic strategies to prevent, treat, and cure heart, lung,
blood, and sleep diseases. Under the expert supervision of her mentors, Grace will complete the proposed
research and highly individualized training plan to advance a novel line of investigation and facilitate development
towards becoming a successful independent investigator.

Public health relevance
PROJECT NARRATIVE Women who experience gestational diabetes mellitus during pregnancy are at a significantly greater risk of developing cardiovascular and metabolic diseases after pregnancy and because of this, establishing effective strategies to mitigate disease progression in these women is an urgent biomedical research priority. This project will address that priority by investigating the mechanistic contribution of endothelin-1 to attenuated microvascular insulin-mediated dilation in women who had gestational diabetes mellitus, and whether this mechanism is influenced by physical activity and sedentary behavior. This research will aid in the identification of novel therapeutic targets and effective strategies to mitigate the risk of cardiovascular and metabolic disease development in women who had gestational diabetes mellitus.